JHU-UMD Diabetes Research Center

DESCRIPTION (provided by applicant): This proposal seeks continued funding for the JHU-UMD Diabetes Research Center (DRC). The proposed Center will continue to involve investigators from Johns Hopkins University and the University of Maryland. These investigators have primary appointments in numerous departments within and between these Institutions; and while their scientific backgrounds are diverse, they share a common interest in diabetes and endocrinology research and many have established collaborations. The aims of the Center are the following: 1) to foster collaborative, multidisciplinary diabetes and endocrinology research in a supportive environment; 2) to enhance the clinical and basic research capabilities of established diabetes investigators; 3) to encourage investigators not involved in diabetes research to become interested in pursuing problems related to diabetes and endocrinology; 4) to develop, implement and evaluate programs that deliver cost effective health care for the treatment of persons with diabetes; 5) to speed the translation of advances in basic biomedical and genetic research to the clinical arena where they may be applied to the diagnosis and treatment of persons with diabetes; and 6) to inform others in both professional and lay settings of the accomplishments, opportunities and advancements in diabetes research and training. This application contains six separate components: Administrative, Biomedical Research, Pilot and Feasibility, Enrichment, a Regional Shared Resource core, and a Shared Research Core and expansion of the P&F program to a Historically Black University, Howard University College of Medicine. The Administrative Component will be responsible for overseeing the operation of the Center as a whole. The Biomedical Research Component will consist of five Core Laboratories to foster collaborative diabetes research. A Pilot and Feasibility Component will foster the participation and interaction of junior investigators with established investigators in research' related to diabetes. The Enrichment Program will facilitate the interaction within and between Johns Hopkins University and the University of Maryland.

Public health relevance
PUBLIC HEALTH RELEVANCE: The JHU-UMD Diabetes Research Center strives to understand the causes of both type 1 and 2 diabetes and promote translational research that is aimed at reducing the burden of these diseases in the U.S. This center has a unique focus on childhood diabetes and diabetes that affects minority populations.